Functional-neuroanatomy of high-level visual cortex: a quantitative multimodal approach

PROJECT SUMMARY
Humans rapidly comprehend the continuous visual input - perceiving who are the people, what
are their actions, and where are they. These percepts emerge from computations across ventral,
lateral, dorsal streams, respectively. However, it is unknown how the interplay between brain
structure, function, and computation supports these visual behaviors. Leveraging advancements
from the prior funding period, we propose a unique multimodal and computational approach to
answer this question. The research will focus on ventral and lateral streams, as the ventral is the
most understood and the lateral is the least understood. Aim 1 will elucidate the interplay between
function, white matter connections, and cytoarchitecture using functional, anatomical, and
diffusion MRI, as well as cytoarchitectonic data. We will quantitatively measure the relation
between functional and structural data, develop computational models linking these metrics, and
evaluate their predictivity in left out data. Aim 2 will determine the nature of basic spatiotemporal
computations in the visual system and how they affect visual capacity. Aim 2a, will use fMRI and
novel spatiotemporal population receptive field (ST-pRF) modeling to determine how basic
spatiotemporal computations vary with stimuli and attention. Aim 2b, will use fMRI and behavioral
measurements to measure neural and visual capacity, respectively, to multiple stimuli presented
sequentially or simultaneously under different attention conditions. Using ST-pRFs, we will
determine what spatiotemporal computations predict neural capacity, and then develop a linking
model predicting from brain responses visual capacity. Aim 3 will use exciting new topographic
deep neural networks (TDANNs) together with massive fMRI datasets of brain responses to visual
stimuli to determine how behavioral goals and structural constraints affect the function and spatial
organization of the human visual system. This will not only shed important light into the utility of
implementational factors, but also generate a single model linking structure, function, and visual
behavior. The research will (i) significantly advance understanding of the interplay between visual
function, structure, and computations in multiple visual streams filling in longstanding empirical
and theoretical gaps, (ii) generate new computational and theoretical understanding how basic
spatiotemporal computations and structural constraints affect visual processing, and (iii) generate
innovative open source empirical and computational methodologies. This research has important
health ramifications for developing noninvasive diagnostics for clinical conditions associated with
malfunction of high-level visual cortex including prosopagnosia, action agnosia, and dyslexia, and
will provide a new computational testing bed for developing cortical visual prosthetics.

Public health relevance
PROJECT NARRATIVE Our proposed research is in-line with the mission of the NEI to understand the human visual system and train talented and diverse individuals, strengthening the vision research workforce. We expect our proposed research to significantly advance understanding of the relation between structure, function and computations in the human visual system. The outcome of our research will enhance the health of individuals as it will provide foundational knowledge that can lead to developing noninvasive diagnostics for clinical conditions associated with malfunction of visual cortex and will provide a new computational testing bed for developing cortical visual prosthetics.